Interdepartmental Neuroscience Training

Use continuationpages as neededto provide the required information in the format shown below. University of Rochester School of Medicine & Dentistry 601 Elmwood Ave Rochester, NY 14642 Start with the Principal Investigator. List all other key personnel in alphabetical order, last name first. Name Organization Role on